Planning & Evaluation Core (PEC)

Planning and Evaluation Core
The Planning and Evaluation Core (PEC) is comprised of the Partnership’s Administrative Core, Internal Advisory Committee, Program Steering Committee, Executive Committee and external evaluator to provide oversight of the overall Partnership activities and programs. It will be responsible for all aspects of planning, monitoring, evaluation, and tracking of Partnership Translational Cancer Research. In addition, this core serves as a platform from which the Partnership’s PIs can discuss strategic plans that can move the U54 Partnership towards new initiatives that strengthen the goals and mission of both institutions. The PEC specific goals and objectives are: 1) In collaboration with the Administrative Core, the Partnership PIs (Drs. Ahles, Gany, Espinosa and Vuong) with the Internal Advisory Committee and the Program Steering Committee, will work to ensure ongoing planning, monitoring, evaluation and tracking of Partnership activities including: a. Coordination and management of the solicitation of new research proposals; b. Review and selection of Pre-Pilot, Pilot, and Full Projects for funding, monitoring of project progress, and decision-making regarding discontinuation of funding for projects not meeting goals; c. Development of new initiatives based on opportunities presented on a national level (e.g., RFAs and PARs issued) or at either institution; d. Identification of faculty searches that are potentially synergistic with Partnership goals; 2) To use mixed method approaches to monitor and evaluate all aspects of Partnership functioning, in collaboration with the external evaluator, Dr. Robin Isserles, to: a. Track pertinent data that monitors and assesses the Partnership’s goals and objectives, such as publications and grant submissions by investigators, student tracking data, and community outreach assessments; b. Review all aspects of Research Project development and implementation; c. Evaluate all aspects of the proposed educational programs implemented through the Research Education Core (REC); d. Utilize the RE-AIM framework to monitor and evaluate all aspects of the proposed Partnership Community Outreach, Research, Education/Engagement Core (PCORE) activities; e. Ensure that the LinguistiC Responsiveness Shared Resource Core (LCRSRC) meets target metrics, also guided by the RE-AIM framework; f. Record, monitor, and assess all administrative support activities, resources, and programmatic measures, and, in concert with the Administrative Core, track and monitor short- and long-term impacts of the Partnership.